Preventing Early-Onset Colorectal Cancer inthe VA Using a Multilevel Screening Intervention

Background: Incidence and mortality of early-onset colorectal cancer (EOCRC), defined as colorectal cancer
(CRC) diagnosed before age 50 years, has been increasing in the US since the 1990s. In response to these
concerning trends, in 2021 the US Preventive Services Task Force recommended lowering the age to initiate
CRC screening from 50 to 45 years. Within the VA health care system, 60% of eligible individuals aged 50-75
years and only 42% of those aged 45-49 years were up-to-date with screening in May 2024. Younger
individuals are less likely to perceive the need for screening, but informing individuals who are at higher risk
about their status may increase their interest and participation in screening.
Significance: CRC is a leading cause of cancer death among Veterans. To maximize CRC screening benefit
in individuals younger than 50 years, it is critical to 1) identify high-risk individuals in this age group who may
be targeted for screening and 2) assess the effectiveness and implementation of interventions to promote
screening in all younger individuals.
Innovation & Impact: Currently there are no risk scores for EOCRC in clinical use, and risk scores developed
for research often use genetic and survey data but omit more readily accessible information from the electronic
health record (EHR) to identify individuals at increased risk. In addition to identifying high-risk individuals, it is
also crucial to study interventions that will increase screening in the younger population. Otherwise, data show
that younger adults are less likely to engage in screening and passive adoption of new clinical guidelines
occurs slowly among physicians.
Specific Aims:
Aim 1: To develop and validate a risk score for EOCRC using EHR data
Aim 2: To determine the effectiveness of a multilevel intervention to increase screening in individuals aged 45-
49 years, using personal risk as a motivator for high-risk individuals.
Aim 3: To evaluate the implementation of the multilevel intervention.
Methodology: We plan to 1) build and validate an EOCRC risk score using EHR data from the VA Corporate
Data Warehouse (CDW), 2) identify a prospective cohort of Veterans aged 45-49 years and conduct a 2x2
factorial multilevel intervention that includes informing high-risk patients and their primary care providers about
their risk status, and 3) assess for barriers and facilitators to implementing the multilevel intervention through a
qualitative process evaluation with key informants.
Next Steps/Implementation: If this novel risk stratification strategy to prevent EOCRC is effective at a single
site, then we will work with partners to implement it throughout the VA and test it outside of the VA system.

Public health relevance
Colorectal cancer is a leading cause of cancer death among Veterans. The starting age for colorectal cancer screening has been lowered from 50 to 45 years in response to the rising incidence of early-onset colorectal cancer (EOCRC), but how to best engage younger Veterans in screening is unclear. We will 1) develop and validate a novel risk score for EOCRC derived from the VA electronic health record data, 2) conduct a multilevel screening intervention that targets individuals aged 45-49 years and informs high-risk individuals and their providers about their risk status for EOCRC, and 3) determine barriers and facilitators to implementing the intervention using a qualitative process evaluation. The overall goal of this study is to create and test a risk stratification approach to prevent EOCRC, which may be especially useful for younger individuals who are less likely to participate in preventive care.